Regulated RNA Splicing Response to Endurance Exercise

Abstract
The role of exercise in improving health and fitness has become an increasingly important area of scientific
research. The MoTrPAC multiomic rat endurance exercise training (EET) study has convincingly shown that
the effects of exercise are pervasive throughout the body and these effects are found at all omic levels. The
study measured the effects of up to eight weeks of EET on transcriptomic, epigenomic, proteomic and
metabolomic features across up to 19 tissues in male and female rats. In order to fully understand the
mechanisms by which exercise impacts the body and health, we need a whole body, multiomic model of the
regulatory networks that drive EET-induced molecular changes. One critical aspect of gene regulation that was
overlooked in the MoTrPAC rat data analyses is exercise-regulation of alternative mRNA splicing (AS). Initial
studies of the acute human MoTrPAC data show dramatic regulation of AS by acute exercise in the limited
tissues sampled in that study. This indicates that exercise-regulated splicing is an important mediator of the
effects of exercise and motivates our proposed study of the effects of EET throughout the organism. We
propose to develop a 19 tissue map of the AS landscape, both at baseline and in response to EET. This will be
an unprecedented diversity of tissues with which to explore AS behavior. By integrating these results across
omes, we can elucidate both what is changing in the AS landscape and how it affects downstream gene and
protein activity. In addition, we can use epigenome and transcription factor activity analyses to identify the
mechanisms underlying AS regulation. First, we will measure baseline un-exercised tissue specificity of AS
events, and second, we will find differential AS events (DASs) in response to one, two, four, or eight weeks of
EET. We will modify bioinformatic integration tools developed by our team to optimize integrated analysis of
splicing and regulatory mechanisms, including PLIER to look for cross-tissue patterns of AS response to EET
annotated to enriched pathways and MAGICAL to generate regulatory circuits of coordinated EET responses in
chromatin accessibility or DNA methylation with DASs and enriched transcription factors. This knowledge will
be a valuable resource for future AS analysis in general and, specifically, in studies of exercise. Because most
of the tissues included in this study cannot be analyzed in human subjects, we will use these results as a
foundation for future grant proposals seeking to connect the 19 tissue AS responses in rat to human
understanding of the AS landscape.

Public health relevance
Project Narrative The role of alternative mRNA splicing in the response to exercise training has not been well characterized, despite the known importance of splicing in gene regulation, and the growing importance of exercise research to future human health. The MoTrPAC multiomic rat endurance exercise training study provides an incredible opportunity to create a map of the alternative splicing landscape at an unparalleled scale of tissues. We will implement cutting edge multiomic machine learning tools to investigate the cross-tissue patterns of alternative splicing response to exercise training as well as the regulatory circuits driving this response.